Revealing the Molecular Basis of Microtubule-Intermediate Filament Interactions.

Project Summary
Microtubules (MTs) and intermediate filaments (IFs) are two main components of the cytoskeleton in eukaryotic
cells, each with unique structural and regulatory roles. Interactions between MTs and IFs are crucial for
maintaining cellular shape, stability, and organization. Despite their wide importance in biology, exactly how MTs
and IFs interact at the molecular level remains unclear. A major barrier to elucidating these interactions is
the strong context-dependency of cytoskeletal arrangement and function across tissues, cell types, and
subcellular locations. MTs and IFs are specialized by subunit composition, bound proteins, and post-
translational modifications to create polymers with distinct physical properties, interaction networks, and
regulatory mechanisms. Understanding how MTs and IFs are adapted to form morphologically and functionally
distinct cytoskeletal arrays will have broad applications in developing therapeutic strategies, improving tissue
engineering, and advancing our knowledge of cellular mechanics.
The goal of this proposal is to reveal the molecular adaptations of MTs and IFs that regulate cytoskeletal array
configuration and function specifically in myelinated axons, which are important for rapid, long distance neuronal
communication. All axons contain a staggered, parallel array of highly decorated MTs and neuron-specific IFs
called neurofilaments (NFs) that locally regulate cell shape and composition. Myelinated axons regulate their
cytoskeletal array through a phosphorylation cascade that directly targets MTs and NFs to change their
abundance and rearrange their 3D organization. My research plan builds on the implementation of a novel
method for isolating myelinated axons from the brain that preserves the internal configuration of MTs
and NFs and will for the first time enable the study of tissue-derived material in its native form. This
multifaceted work combines structural determination, biochemical assays, comparative proteomics, and
immunofluorescence aiming to reveal how MTs and NFs are adapted and interact inside myelinated axons.
Atomic structures of native MTs and NFs determined by cryo-electron microscopy (cryo-EM) will reveal the
molecular mechanisms behind their exceptional stability inside the axon, which is important for maintaining cell
integrity. Complementary biochemical analyses will investigate how MT and NF turnover is regulated to influence
cytoskeletal array composition. To further identify regulators of the MT-NF array, focused ion beam milling (FIB-
milling) and cryo-electron tomography (cryo-ET) will reconstruct entire cytoskeletal networks within intact axons
to quantify MT-NF network organization and association with cellular cargo. Altogether, support of this research
by the R35 MIRA award would establish a framework for future studies on cytoskeletal adaptations in different
biological contexts and disease states throughout my career.

Public health relevance
Project Narrative This proposal seeks to deepen our understanding of the molecular interactions between microtubules and intermediate filaments by determining how they are adapted across cell types and subcellular locations. With a focus on the specialized mechanisms regulating microtubules and neurofilaments, the proposed research will provide fundamental insights into key processes supporting cellular function ranging from physical integrity to cargo distribution.